Targeting natural killer cells to HIV in intravenous drug users

Project Summary/Abstract
Harnessing our immune system to fight HIV presents tantalizing possibilities. An effective vaccine could
prevent the ~2 million new infections that continue to occur each year, and immune targeting of latently-
infected cells could significantly advance cure strategies. However, the traditional approaches based on
eliciting adaptive B and T cell responses have typically led to narrow immune responses that are not effective
against the vast diversity of HIV strains circulating worldwide. The challenge is more acute for individuals
infected through injection drug use, as current vaccine efforts are exclusively focused on sexually-transmitted
HIV strains, which typically establish infection with only a single strain and must pass through an epithelial
barrier to establish infection. In contrast, individuals who are infected with HIV through injection drug use are
more likely to be infected with multiple strains with different antigenic properties. We propose pioneering a
novel approach to improve immune targeting of HIV by harnessing natural killer (NK) cells, with a particular
emphasis on the unique strains transmitted through injection drug use.
We have exciting new data indicating that NK cells have a surprising degree of specificity in their antiviral
responses. The communication between the NK cell and an infected can control the quality and the quantity of
the immune response, affecting the balance between killing of infected cells and secreting cytokines that can
enhance or dampen the immune response. In order to define the mechanisms that control the quality of the NK
cell responses to HIV, we propose identifying the viral components that drive NK cell activation and escape,
and how these components differ in HIV strains transmitted through injection drug use. Using advanced single-
cell techniques, we will also define the precise NK cell subsets and activation pathways required to generate
an effective NK cell response and how control of these pathways is maintained at the epigenetic level.
Together, these approaches will identify the viral and cellular components required for specific innate targeting
of HIV, allowing us to make informed choices in the development of vaccines and therapeutics to elicit NK cell
responses that promote viral eradication.

Public health relevance
Project Narrative Harnessing the immune system to fight HIV provides the best hope for HIV eradication. However, current approaches focus on adaptive immune responses and on targeting HIV strains transmitted through sexual contact, which could differ in important antigenic properties from those transmitted through injection drug use. Here we propose a new approach to fight HIV, in which we tune NK cells to optimally target HIV strains in injection drug users to develop new prevention and cure strategies.